Case Comprehensive Cancer Center NCTN Lead Academic Participating Site

PROJECT SUMMARY
This project represents the comprehensive efforts of the oncology community at Case Western Reserve
University School of Medicine and its three major teaching affiliate hospitals (University Hospitals, Cleveland
Clinic, and MetroHealth) to participate as a Lead Academic Participating Site in the National Clinical Trials
Network (NCTN). The NCTN, funded and directed by the National Cancer Institute (NCI), is the major consortium
for performing federally-funded, national multicenter clinical trials that aim to improve outcomes for cancer
patients. The emphasis of NCTN trials is late phase (phase III and relatively large Phase II) trials that address
scientific questions that usually cannot be answered by other means such as a single-institution study or an
industry company study. The results of these trials often set the standards of care for cancer treatment in the
U.S. and the world. This includes clinical trials research in rare cancers and underrepresented populations. Our
specific aims for this project are 1) to participate in NCTN trials with exceptionally high levels of accrual volume
and quality of data generation and submission for approximately 240 new patients per year; 2) to serve the NCTN
and the cancer community by providing scientific and administrative leadership in the (Cooperative) Groups that
design and operate these NCTN clinical trials in the entire broad portfolio of cancers; in particular we are full
members with many investigator leaders within NRG Oncology, ECOG-ACRIN and SWOG; and 3) to perform
and present hypothesis-based, investigator-led research that benefits future NCTN research. This includes
secondary clinical and biorepository translational analyses from NCTN data and pilot studies from our institution.
We achieve these aims by assembling an outstanding core of investigators representing all the major cancer
specialties (surgical, radiation, medical and diagnostic oncology) and disease sites (hematologic, lung, breast,
gastrointestinal, genitourinary, brain, gynecologic and melanoma). We have also developed a robust
infrastructure of clinical trials operations in support of the NCTN, including the centralized facilities at Case
Western and the hospital-based clinical trials units. They ensure timely activation of, and education about, NCTN
trials, accrual enhancement, regulatory management and a high quality of research procedures and data
submission. Finally, a major priority is the recruitment, development and mentoring of new Case Western
investigators' involvement within the NCTN, including their participation in the Groups' activities such as their
semi-annual meetings and committee assignments.

Public health relevance
PROJECT NARRATIVE The Case Comprehensive Cancer Center Lead Academic Performance Site Program aims to advance the mission of the National Clinical Trials Network (NCTN) in bettering quality of life, treatments, and cures for patients with cancer through prospective clinical trials. We strive to lead this effort by developing the treatments of the future, collaborating nationally, and making these cutting-edge therapies available to improve the lives of cancer patients we serve in Northeast Ohio.